Investigating the role of brain-engrafted monocyte-derived macrophages in Alzheimer's disease

PROJECT SUMMARY
Alzheimer’s disease (AD), the leading cause of dementia worldwide, affects millions of individuals and presents
a major public health challenge. Microglia, the resident macrophages in the brain, adopt a range of activation
states, displaying functional heterogeneity that spans from neuroprotective to neuroinflammatory roles in AD.
Deciphering the heterogeneity of brain macrophage is essential for understanding the immune mechanisms
driving AD pathogenesis. A key factor shaping macrophage heterogeneity is their ontogeny, as the
developmental origin of macrophages plays a critical role in defining their identity and function. Microglia were
thought to originate solely from yolk sac (YS) progenitors and maintain themselves through self-renewal without
contributions from peripheral cells. However, recent studies suggest that monocyte-derived macrophages
(MDMs) can infiltrate the brain under certain conditions, such as in mouse models of amyloidosis, adding to the
heterogeneity of brain macrophages. However, the role of brain-engrafted MDMs in AD pathogenesis remains
unclear. This research proposal aims to elucidate the contributions of brain-engrafted MDMs to AD pathology in
both mouse models and human AD. In the F99 phase, I will investigate the effects of brain-engrafted MDMs on
amyloid plaque deposition in the 5xFAD mouse model. Specifically, I will assess how promoting (Aim 1.1) or
depleting (Aim 1.2) brain-engrafted MDMs affects amyloid accumulation and cognitive decline, providing insights
into the functional role of MDMs in AD progression in mice. In the K00 phase, I will focus on studying human AD,
utilizing somatic mosaicism as a method to trace brain-engrafted MDMs and investigate the role of AD-
associated somatic mutations in human iPSC-derived microglia. A recent study revealed an enrichment of
somatic mutations in AD patient microglia, suggesting that mutation-driven clonal expansion may contribute to
AD pathology. However, it remains unclear whether MDMs infiltrating the human AD brain contribute to this
mutational burden. I will analyze microglia and paired blood monocytes from AD patients and controls to
determine whether peripherally-derived MDMs contribute to the increased somatic mutations observed in AD
microglia. Additionally, I will introduce the top AD-associated somatic mutations into iPSC-derived microglia to
assess their functional impacts on microglia. The successful completion of these studies will deepen our
understanding of brain macrophage heterogeneity, particularly the distinct roles of MDMs versus YS-derived
microglia in AD. This work holds the potential to uncover novel therapeutic targets aimed at slowing disease
progression and improving outcomes for AD patients.

Public health relevance
PROJECT NARRATIVE The research proposal focuses on understanding how brain-engrafted monocyte-derived macrophages (MDMs) contribute to Alzheimer’s disease (AD) progression. By studying both mouse models and human samples, I aim to determine whether these immune cells play a harmful or protective role in the brain during AD. This work is important because it could provide us with new insights to understand macrophage heterogeneity in AD, potentially uncovering novel therapeutic targets to slow disease progression for AD patients.